Dynamic regulatory mechanisms of robust pattern formation in the neural tube

ABSTRACT
Dorsoventral (DV) patterning of the vertebrate neural tube has served as a model system for understanding
how cells acquire position-dependent cell fates during development. The reigning paradigm for patterning is
based on the French flag model, which suggests that cells along the DV axis of the neural tube reside in a
gradient of an extracellular morphogen and interpret the concentration of this signal to assume specific fates.
This model overlooks the highly dynamic nature of the tissue leading up to neural tube formation, during which
cells move large distances through multiple spatiotemporally varying signaling gradients. Our previous work
on this grant has revealed critical gaps in the current understanding, highlighting the need for a
comprehensive analysis that takes into account the dynamics of the system as well as the role of a
multiplexed, noisy signaling environment. Here we seek to address this challenge by taking advantage of the
zebrafish model system and leveraging our expertise in high-resolution 4-D microscopy, single-cell
transcriptomics, and systems-biological approaches in vivo. Based on our work and recent work from other
labs, we hypothesize that cells in the nascent neural tissue perceive multiple time-varying signals as a
consequence of complex morphogenetic movements during gastrulation, which are processed by a gene
regulatory network (GRN) to initially ‘pre-pattern’ the neural plate. We suggest that pre-patterning integrates
with subsequent dynamic signaling in the neural tube to enable precise DV patterning. To investigate this idea,
in Aim 1 we will first systematically characterize pre-patterning in the zebrafish neural plate by generating a
spatial atlas of transcription factor (TF) expression. We will then analyze whether and how pre-patterned TFs
contribute to neural tube fates using fate-mapping approaches as well as a novel in vivo Perturb-seq
technique, which combines multiplexed CRISPR/Cas9 perturbation of TFs with single-cell RNAseq for large-
scale functional analysis. Finally, guided by mathematical modeling, we will analyze how pre-patterning
contributes to the precision of neural tube patterning using perturbation studies. In Aim 2 we will analyze how
multiplexed, dynamic signaling in the gastrula leads to neural pre-patterning. Starting with a single-cell level
characterization of the signaling landscape of the nascent neural plate, we will combine signal perturbations,
TF Perturb-seq, and mathematical modeling to dissect how a neural GRN processes temporally varying
signaling to establish a pre-pattern. Together, this work will provide a comprehensive view of neural tube
patterning, elucidating how it is accomplished in the early embryo through multiple dynamic signals interacting
with organized tissue movements. Furthermore, we expect that the conceptual ideas and approaches
developed here will be broadly applicable to understanding robust patterning across developmental systems
and organisms.

Public health relevance
NARRATIVE How multicellular organisms arrange different types of cells into precise spatial patterns is a question of fundamental importance. Here we seek to identify regulatory motifs that allow multiple secreted signals to result in precise patterns despite multiple sources of variation such as cell movement, gene dosage, and noisy gene expression. We expect that the principles we find here in the context of spinal cord patterning will be broadly applicable to other tissues and biological engineering.